Immunologic aspects of targeted therapy of erbB tumors

Our overall hypothesis is that ordered therapy with oncoprotein disabling mAb followed by IFN-γ leads to
phenotypic changes in tumor cells never achieved with mAb itself. MAb induced phenotypic changes sensitize
cells or are permissive for unexpected actions of IFN-γ directly on the tumor. The overall goal of this proposal
is to gain a deeper understanding of events of erbB mediated tumorigenesis and to develop more potent
therapeutics to treat and prevent the emergence of resistant tumor formation and spread. We will employ
MMTV NeuT-tdTomato transgenic mice created to express MMTV-neu proteins in Tomato tagged mammary
cells and which develop breast tumors stochastically much like human breast cancer. These unique
transgenics will be subjected to the effects of targeted therapy against the p185 oncoprotein followed by or
concurrent with IFN-γ therapy. Tumor emergence and spread will be followed and cell lines developed from
progressive tumors for further biochemical studies. Other studies will employ paired administration of anti-p185
mAb and IFN-γ, as well as use of a new species of anti-erbB2-scFv with a modified effector domain to which
we have genetically attached the IFN-γ molecule. The MMTV NeuT-tdTomato transgenic mice will be hosts to
follow the effects of mAb alone, or in combination with IFN-γ, on tumor progression and metastatic spread.
Resistant tumors that arise despite treatment with mAb to p185neu will be studied for phenotypic and allelic
changes that occur in the tumor itself, through the use of propogated cell lines, in particular genes we have
considered to be relevant to the malignant phenotype. Our studies on a newly engineered mAb humanized
mAb-IFN-γ recombinant protein fused with a humanized ZZ domain, (which we term the ZED domain) will be
extended to Herceptin resistant breast cancers. This highly engineered mAb species simultaneously disables
p185erbB2/neu kinases; amplifies immunoglobulin effects through the ZED domain; and, finally, delivers
IFN-γ directly to human tumor cells. We will evaluate if effector domain modified targeting anti-erbB2 mAb also
affects cells transformed by both the erbB2/neu oncogene and other somatic mutations such as KiRas. This
construct may be a prototype of a therapeutic for human disease. Finally, we will also evaluate if
cytotoxic/genotoxic signals (such as the taxane, docetaxol) used with this new species of antibody further
eliminates Herceptin resistant tumor cells.

Public health relevance
These studies extend basic molecular and immunologic analyses of the malignant characteristics of breast cancer cells that arise despite targeted therapy. We have developed a new therapeutic approach to prevent both breast cancer emergence and treat resistant cancer spread. This approach has the potential to increase patient survival rates and reduce the amount of targeting antibody and toxic chemotherapeutic drugs.